Automated aquatic husbandry equipment to enable rigorous and reproducible axolotl studies

PROJECT SUMMARY: Axolotl salamanders are model organisms offering researchers unique
opportunities to explore fundamental mechanisms underlying a variety of biomedically-relevant phenomenon.
The Harvard Axolotl Facility (HAF) houses one of the most robust research colonies of axolotls in the U.S. This
is a shared-use facility overseen by Dr. Jessica Whited. This proposal requests support to modernize the HAF,
increasing its efficiency and capabilities by the addition of three double-sided flow-through racks for axolotl
aquaria featuring real-time water quality measuring and adjusting functions.
Axolotls have limbs which are anatomically and functionally similar to human limbs, yet axolotls can
completely regenerate limbs throughout life. Elucidating how axolotls regenerate limbs will provide critical clues
for scientific efforts aimed at therapeutic limb regeneration in human patients in the future. The precise genes
whose activity enables limb regeneration can now be defined with the advent of appropriate experimental tools
and genomic resources in axolotls. On the Harvard campus, axolotls are being used collaboratively to address
fundamental questions such as: potential metabolic trade-offs associated with appendage regeneration (Dr.
George Lauder); connections between regeneration and cancer (Dr. Brian Haas); how stress pathways
intersect with stem cell activation following amputation (Dr. Isaac Chiu), and central nervous system regulate—
or respond to—limb regeneration (Dr. Jia Liu). Our use of axolotls goes beyond limb regeneration.
Researchers are using HAF’s axolotls to study the evolution of novel sensory traits (Dr. Nicholas Bellono),
evolutionary aspects of pain sensation (Dr. Will Renthal), and evolution of skeletal morphologies such as pelvis
(Dr. Stephanie Pierce). Thus, the HAF is truly a multi-use facility that has supplied a variety of labs with high-
quality research organisms for study.
Axolotls are permanently aquatic, and they are also cannibalistic. To generate and grow axolotls to
appropriate sizes for experiments, they must be bred in-house and raised in separate enclosures, ensuring
they are completely naïve to injury at the onset of studies. We are also generating targeted alleles of axolotls
and transgenics. These animals must be raised to adulthood to establish lines, yet the axolotl generation time
is one year. Thus, there is significant need for axolotl housing in the facility that is standardized and robust in
the face of environmental fluctuations. Automation is key to the management of a modern axolotl facility, yet
equipment for automation can be expensive and difficult to fund from traditional sources. Equipment requested
will provide hundreds of individual enclosures for live axolotls to live with minimal environmental fluctuation and
minimal human caretaker intervention, thereby simultaneously improving rigor and reproducibility while also
improving efficiency. Together, these improvements will greatly enhance the rigor, reproducibility, and
efficiency of research programs on campus using the axolotl model system.

Public health relevance
PROJECT NARRATIVE Axolotl salamanders are powerful experimental models for exploring a variety of important biomedical questions, yet they require specialized aquatic facilities and equipment for housing to enable rigorous and reproducible research. This proposal will support a shared-use aquatics facility for axolotl used for biomedically-relevant research, including research directed at understanding natural vertebrate limb regeneration. The proposed equipment will directly enable more efficient and reproducible husbandry workflows to raise axolotls for experimentation and for establishment of genome-edited and transgenic lines.